Rutgers-NYU Center for Asian Health Promotion and Equity

Overall – Abstract
In response to RFA-MD-21-007, we propose the Rutgers-NYU Center for Asian Health Promotion and Equity
(CAHPE) to advance interdisciplinary research on comorbid cardiometabolic disease and mental health of Asian
adults. There are currently significant disparities in relationship to Heart and Mind, with lower thresholds for BMI
for Asians and disproportionate disparities related to cardiometabolic disease and mental health. Such an
important focus in research, population and investigators will inform both practice and policy at community,
regional and national levels. Asians are the fastest growing yet most understudied US minority group at 23 million
people and growing 26% from 2010-2019. Yet, < 1% of NIH research funding in the last 10 years were focused
on US Asian populations. Moreover, this population experiences the “Asian Paradox”: while on average, US
Asians, are the highest-income earners and the most highly educated, more Asians, especially older adults, live
below the poverty line, are less likely to participate in biomedical research, and suffer disproportional health
disparities compared to white Americans. These health inequities are further complicated by the heterogeneity
of these immigrant populations, especially with respect to culture, religion, language, sexual identity, and trauma
exposure, many of which challenge our assumptions about the “model minority” stereotype.
Building on two decades of rigorous aging research in minority populations and track records of
successful academic achievements, we have leveraged strong existing transdisciplinary partnerships across
multiple academic and community institutions to build a center designed to foster the next generation of diverse
researchers in a nurturing environment that is conducive to success and promotes highly relevant and rigorous
translational research on cardiometabolic and mental health outcomes among US Asians. With strong
institutional support of $3 million in matching funds, our Center will have five inter-connected aims: 1)
Provide leadership, organizational communication, and evaluation systems designed to achieve the overarching
goals of supporting high quality and enduring inter-disciplinary research on cardiometabolic and mental health
outcomes among Asian adults; 2) Guide solicitation and selection of 6 pilot studies per year; 3) Implement the
three interdisciplinary, translational, and synergistic R01-like projects with specific focus on: Nutritional, Positive
Affect, and Dementia Caregiving Interventions to multi-prong target diverse Asian population at high risk; 4)
Enhance, track, and evaluate existing infrastructure to support and synchronize the pilot and center projects;
and 5) Disseminate these findings to the local, regional, and national levels in order to inform the design of future
prevention/intervention research commodities. The overall aims of this application reflect the synergistic work of
the Administrative Core (AC), Investigator Development Core (IDC), Community Engagement Core (CEC), and
research projects.

Public health relevance
Overall – Narrative Despite the rapidly growing US Asian population, there are vast gaps in translational research on comorbid cardiometabolic and mental health outcomes. In the Rutgers-NYU Center for Asian Health Promotion and Equity, we will establish three complementary cores and three research projects to achieve the mission of the center: to improve cardiometabolic and mental health of US Asians through a robust research infrastructure and resource structure and developing the next generation of scientists focused on these health disparity issues.